THE STRUCTURE AND DYNAMIC PROPERTIES OF MACROMOLECULES

A. Macromolecular structure, dynamics and polyelectrolyte properties of large biological polymers, in particular, polynucleotides and nucleic acids are being studied by electric-field induced dichroism and birefringence methods. Theoretical and computational methods supplement the experimental work.